Origin Recognition Complex and Transcriptional Silencers

Project Summary: Included in Research Strategy section as required for this mechanism.

Public health relevance
Project Narrative: Not required for this mechanism